Research Training in Mood and Anxiety Disorders: From Animal Models to Patients

The purpose of this proposed renewal is to continue training postdoctoral (MD, MD/PhD, and PhD) fellows for
careers as independent researchers. Since its inception in 1978, the program described in this application has
successfully prepared individuals for careers in Mood and Anxiety Disorder research, evolving over the course
of nearly half a century to continue training investigators who will have a significant impact in their fields. The
success of our program is measured by how many fellows continue in a research-intensive trajectory whether
supported by a K award, other sources of funding, or other positions that advance the research enterprise. The
program itself is an intensive three-year program where fellows learn to identify key research questions, formulate
hypotheses, and design and execute experiments that test those hypotheses. Other skills required for a fellow
to become an independent researcher include understanding the administration of a successful research
enterprise, effective collaboration and writing grants. Comprehensive training in the Responsible Conduct of
Research begins early in the fellowship. Our fellows our taught to maintain the highest standards of scientific
integrity and understand the ethical issues relevant to human and animal research.
In this renewal application we are seeking five years of funding for 6 fellows per year. Fellows are carefully
selected for particular interest in clinically relevant research interests and screened by our committee for their
potential to benefit from our program and succeed as independent investigators. Admitted fellows are paired
with a primary mentor in one of several areas of focus. These include amongst others, mouse models of neural
circuit function and dysfunction relevant to mood and anxiety, functional neuroimaging, theoretical approaches
for understanding circuit function and dysfunction that is relevant to cognition, emotion and psychiatric illness,
and neurodevelopmental perspectives on the abovementioned areas. The fellows are exposed to a training
program that provides ‘wrap around’ mentoring, support and didactics well beyond what is usually encountered
in a post-doctoral position. This includes ‘meta’ mentorship from the program and training directors who help
trainees to become more effective mentees and who work with mentors to ensure that they are meeting their
trainees needs. The program provides didactics in research design, statistics, responsible conduct of research
and grant writing to all fellows, with additional coursework tailored to individual fellows needs. Through a bi-
annual review with the fellows or their independent development plans, the directors ensure that trainees are on
track to meet their goals in submitting scientific papers for publication and in generating data for future grant
submissions. New directions include the expansion of the fellow seminar program to include presentations by
fellows in all three years, providing an opportunity to give stage appropriate presentations of their work and
receive feedback. This seminar program has the additional advantage of providing a larger community of
research minded individuals interested in a broad range of mental health research areas.

Public health relevance
PROJECT NARRATIVE This program trains MDs, MD/PhDs, and PhDs for careers as independent researchers. A program didactics and execution of research is described. Fellows learn to identify research questions, formulate hypotheses, and design and execute experiments to test those hypotheses.